IMMUNOREGULATION IN VIVO AND IN VITRO BY CYTOKINES

In order to understand the mechanism of antitumor effects, we are investigating the role of cytokines in the regulation of immunity in vitro and in vivo. Interferon-alpha (IFN-alpha), IL-2, IL-6 and other cytokines are investigated. Our initial paper in which we demonstrated that IFN- alpha synergized with IL-2 in the augmentation of lymphokine activated killer (LAK) cells in various compartments of mice is in press. Both proliferation and augmentation of LAK cell activity on a per cell basis was observed in response to IFN-alpha and IL-2 therapy. Our observations suggest that anti-tumor effects of IFN-alpha with IL-2 may be mediated by the activation of LAK cells. It is of interest that the administration of IFN-gamma with IL-2 caused increased LAK activity while it has not been shown to cause synergistic anti-tumor effects. Other effectors such as CTL, macrophages and unknown population may be responsible for the differences observed with the two interferons. Currently, CTL response after IL-2 and IFN-alpha or IFN-gamma administration and augmentation of LAK activity in response to IFN-alpha and gamma alone are being examined. We are also examining the immune regulatory effects of IL-6 in vivo. This project is still active.